The Toll-like receptor pathway in Meniscal Injury and Osteoarthritis

DESCRIPTION (provided by applicant): Candidate: Carla R. Scanzello, MD PhD is an Assistant Professor of Medicine at Rush University Medical Center (Chicago). She has recently been recruited there to the Faculty of the Department of Medicine (Section of Rheumatology), having completed her Fellowship in Rheumatology at the Hospital for Special Surgery in June 2008. She has a particular interest in the role that inflammation plays in osteoarthritis (OA) pathogenesis, which she began to pursue in earnest as a Rheumatology Fellow. During her Fellowship she designed a research project to characterize synovial cell populations and inflammatory mediators in the synovium of OA patients. Since most previously published work on inflammation in OA had focused on patients with advanced disease, her project was designed to characterize the inflammatory reaction in patients with well-defined early disease. This work has resulted in multiple manuscripts (one published, one accepted, and one under preparation), and observations from this project have led to the hypothesis addressed in this application. This award will allow Dr. Scanzello to gain further training in specific laboratory techniques used in the fields of both Immunology and Cartilage Biochemistry, in order to gain full independence as an investigator. She is committed to pursuing a translational research career working at the intersection between matrix biochemistry and immunology as it applies to OA pathophysiology, with the ultimate goal of developing novel therapies for this common disease in its early stages. Environment: Dr. Scanzello has recently accepted a tenure-track position in pursuit of her goal of becoming an independent investigator. This position allows her the access to resources she will need to accomplish the goals of this proposal. Necessary resources she will have access to include faculty expertise and support, suitable mentorship, accomplished clinical and research collaborators, adequate laboratory space and equipment, and access to appropriate patient populations via the Orthopedics Department. 75% of her time is dedicated for research, with protection from excessive teaching and administrative requirements. The Section of Rheumatology is dedicated to support her efforts to gain independence, and is supporting a research technician to help her accomplish her goals. The expectation is that she will establish a research program with focus on inflammatory pathway activation in Osteoarthritis, an area of research that is just beginning to emerge. Research: Once considered primarily a degenerative cartilage condition, we now understand that the entire joint (including bone, synovium, menisci, and periarticular soft tissues) is altered in OA. Perhaps the least understood pathologic change that occurs in the OA joint is the inflammation within the synovial membrane (SM). This inflammation can be a source pain3, and may stimulate progression of joint degeneration in certain patients4. However the precise inflammatory stimuli in the joint and the downstream mediators remain unknown. We recently demonstrated that the pro-inflammatory cytokine interleukin-15 (IL-15) is detectable in the joints of most patients with knee OA seeking surgical intervention for both early and advanced disease7. This cytokine is known to be produced following activation of certain innate immune receptors, the Toll-like receptors (TLRs), implicating their activity in OA. IL-15 has not been documented in OA previously, but its presence implicates activation of TLRs. Furthermore, IL-15 has functions that may be relevant to OA pathogenesis including induction of enzymatic mediators10,11implicated in disease. Therefore, we plan to test the hypothesis that TLR pathway activation leads to induction of IL-15 by joint tissues in the setting of meniscal injury and early OA, and furthermore that IL-15 contributes to the synovial response and cartilage degradation characteristic of OA. We will test this hypothesis through the following specific aims: Specific Aim 1: To demonstrate that TLR-2 or TLR-4 ligands are produced in patients with early knee OA and mensical injury and stimulate IL-15 production. Specific Aim 2: To demonstrate a role for HA oligosaccharides and TLR-activation in IL-15 production by cells and tissues relevant to joint pathology. Specific Aim 3: To establish the action of IL-15 on cartilage, synovium and meniscal tissue. Specific Aim 4: To verify that IL-15 and TLR activation play central roles in OA pathogenensis in a murine model of OA. We hope that these investigations lead to better understanding of the stimulating factors and consequences of a specific inflammatory pathway in early OA, and ultimately to development of novel therapeutics to interfere with this pathway. As we currently have no interventions for early OA that impact disease progression, defining important pathways in early disease is essential.

Public health relevance
Project Narrative - Relevance: Osteoarthritis (OA) is the most common form of arthritis, affecting over 12% of adults in the U.S. and the leading indication for joint replacement surgery. Inflammation is an important cause of pain in OA, but the stimulus and the consequence of inflammation on joint tissues are not well understood. We propose to study how inflammation may be triggered in the joint, and how it may ultimately lead to joint damage. By understanding how inflammation is perpetuated, we may begin to develop new treatment strategies for this common disease. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS Osteoarthritis 1 is the most common form of arthritis, and the major indication for joint replacement surgery in the United States 2. Once considered primarily a degenerative cartilage condition, we now understand that all tissues of the joint (including bone, synovium, menisci, and periarticular soft tissues) are altered by this complex disease. Perhaps the least understood pathologic change that occurs in the OA joint is the inflammation within the synovial membrane (SM). Synovitis can be a source pain 3, and is related to progression of joint degeneration 4. Murine models demonstrated a role for synovial macrophages in osteophytosis and cartilage destruction 5, 6. However, the precise inflammatory stimuli and the downstream activation pathways remain unknown. We recently demonstrated that interleukin-15 (IL-15) is detectable in the synovium (SM) and synovial fluid (SF) of patients with idiopathic knee OA seeking surgical intervention for both early and advanced disease. 7 Functions attributed to IL-15 and relevant to OA pathogenesis include macrophage activation 8, 9 and matrix metalloproteinase (MMP-1 and -9) production 10, 11. This cytokine is produced in response to ligation of certain Toll-like receptors (TLRs), specifically TLR-2 and -4 12. Our observation of significant intra-articular levels of IL-15 in the vast majority of OA patients suggests that TLR ligation is a universal characteristic of the disease process. Expression of TLR-2 and TLR-4 has been documented in the OA synovial membrane (SM) 13 and in cartilage 14. But the ligands for these receptors in the setting of joint injury and OA are not known. TLRs are best known as innate immune response receptors that recognize "Pathogen Associated Molecular Patterns", or PAMPS 15. However, a growing body of work has identified potential endogenous ligands that may stimulate specific TLRs (TLR-2 and -4), particularly in settings of tissue injury and repair 16. Endogenous activation of TLRs has been implicated in hemorrhage-induced acute lung injury 17, dermal wound healing 18, reperfusion injury 19, 20 and traumatic injury 21. Given the strong association between previous joint injury and OA development 22, we hypothesized that endogenous activation of TLRs may induce the IL-15 detected in OA synovial fluid. Injury models in lung 23 and skin 18 have identified specific low molecular weight forms of hyaluronic acid (HA) as ligands for TLR -4. Low-molecular weight HA is observed in both joint injury and arthritic states 24, 25. We therefore suggest that OA may best be viewed as a "chronic wound" of the joint, in which frequent stimulation of TLRs by endogenous ligands, perhaps low molecular weight HA, may lead to chronic inflammation within the joint. This inflammation may be detected by production of IL-15, but may also ultimately contribute to synovial activation and deregulated chondrocyte function. The specific hypothesis to be tested is that TLR pathway activation leads to induction of IL-15 by joint tissues, and that IL-15 contributes to the synovial response and cartilage degradation characteristic of OA. We further hypothesize that the unknown TLR stimulating ligand in the joint of patients with early OA or meniscal injury may be related to the HA component. We propose to test this hypothesis by addressing the following specific aims: Specific Aim 1: To demonstrate that TLR-2 or TLR-4 ligands are produced in patients with early knee OA and mensical injury and can stimulate IL-15 production. Aim 1.1: Demonstrate that synovial fluid stimulates IL-15 production in a TLR-specific manner. Aim 1.2: Determine whether the TLR activation capacity of synovial fluid is related to HA. Specific Aim 2: To demonstrate a role for HA oligosaccharides and TLR-activation in IL-15 production by cells and tissues relevant to joint pathology. Aim 2.1: Determine whether TLR-2 or -4 ligation induces IL-15 production in chondrocytes and synoviocytes from patients with early OA or meniscal injury, and how TLR activation influences IL-15 isoform and IL-15Rα expression in these cell types. Aim 2.2: Determine if specific HA oligosaccharides can induce synoviocyte or chondrocyte IL-15 production in a TLR specific manner. Specific Aim 3: To establish the action of IL-15 on cartilage, synovium and meniscal tissue. Aim 3.1: Test the ability of IL-15 to induce proteoglycan degradation in cartilage and meniscal explants. Aim 3.2: Determine whether IL-15 can induce matrix metalloproteinase (MMP-1, -3, -13) production by chondrocytes or synoviocytes. Specific Aim 4: To verify that TLR-2, -4 and IL-15 play central roles in OA in a murine model. Aim 4.1: Characterize TLR expression, IL-15 and IL-15 receptor production in the TGFb.OU model of OA (in collaboration with Anna Plaas, PhD and John Sandy, PhD). Aim 4.2: Demonstrate that interruption of TLR activation, or blockade of its downstream mediator IL-15, will ameliorate the development or progression of OA in this disease model.